Metropolitan AntiViral Drug Accelerator

ABSTRACT
The COVID-19 pandemic caused by severe acute respiratory syndrome coronavirus 2 (SARS-CoV-2) has
resulted in millions of deaths worldwide. Novel vaccines against SARS-CoV-2 have altered the pandemic’s
trajectory. Yet, large populations remain at risk, and immune escape virus variants threaten to thwart vaccine
action or current therapies. New small molecule antiviral drugs available as oral treatments in the outpatient
setting are needed to treat SARS-CoV-2 infections, other coronaviruses, and additional viruses of pandemic
concern. COVID-19 has helped rejoin large Pharma in anti-infective drug development but there remains a
gap in the early drug discovery phase, which can be met by academic scientists engaged in drug discovery
through successful partnership with industry. Academic groups have great biological insights and platforms
for novel discovery resulting in identification of new targets, Hits, and Leads. Yet, they rarely have the ways
or means to optimize compounds and advance them for clinical development. We hypothesize that an
effective public-private partnership can bridge this gap and have created the Metropolitan AntiViral Drug
Accelerator (MAVDA). It is an unprecedented collaborative enterprise of academic and Pharma partners in
New York City and Northern New Jersey brought together in a common discovery ecosystem to address the
urgent need for validated small-molecule antiviral drugs. MAVDA combines world-class virologists and
academic drug discovery researchers from Rockefeller University, Columbia University and Memorial Sloan-
Kettering Cancer Center in New York City and the Center for Discovery and Innovation and Rutgers University
in New Jersey with proven antiviral drug developers at Merck & Co., Inc., the Tri-Institutional Therapeutics
Discovery Institute (Tri-I TDI)-Takeda Pharmaceuticals, and Aligos Therapeutics, as a cohesive
enterprise to deliver new antiviral drugs. A critical innovation of the Accelerator is the establishment of an
extensive and integrated network of Pharma-style science cores with highly experienced Core directors, which
ensures that compound identification and optimization proceeds efficiently. Standardized threshold “gating”
metrics for compound progression with clear ‘Go/No Go’ criteria will be established to support development
of qualified drug candidates. MAVDA Projects unite academic and industry investigators with innovative and
well-established drug discovery platforms with a strong emphasis on validated targets like 3CLpro, but also
exploit other important targets like Nsp14 and Nsp16 MTase, ExoN, PLpro, Nsp13 helicase, RdRp, as well as
novel targets. Promising Hits, early Leads, and Optimized Leads at or near the IND enabling/de-risking stage
are represented, along with innovative approaches for new natural product discovery. All programs target
SARS-CoV-2 but also address other coronaviruses, flaviviruses and/or alphaviruses. MAVDA is robust, easily
accommodates Developmental projects and new virus challenges, and it is an ideal environment for training
the next generation of scientists for drug discovery and pandemic preparedness.

Public health relevance
SIGNIFICANCE The COVID-19 pandemic has resulted in millions of deaths worldwide. In addition to vaccines for control and prevention, small molecule drugs are urgently needed in the outpatient setting to treat infections early and prevent new infections in vulnerable populations. We are creating a public-private drug accelerator that unites world-class virologists and academic drug discovery experts with large Pharma and Biotech partners to develop next generation antiviral drugs to SARS-CoV-2 and other pandemic viruses.